Connecting the bacterial metallome to cellular metabolism at single cell resolution

PROJECT SUMMARY
Pathogenic bacteria engage in competition with their hosts for resources. Hosts actively deny resources —
especially transition metals — to invading bacteria to suppress their growth. This is a strategy called nutritional
immunity. Understanding how bacterial populations use metals and how their metal acquisition relates to their
central metabolism is critical to understanding this host-microbe competition and developing new therapeutic
strategies. We currently have a poor understanding both of bacterial metal requirements, and of how bacterial
metal concentrations relate to their central metabolic strategies. The long-term aim of this project is to better
understand the fundamental nature of the relationship between the metal content of individual bacterial cells
within populations of genetically homogenous individuals, and how this relates to variations in their expression
of central metabolism. The first aim of this project is to test the hypothesis that the metal concentrations of
individual bacterial cells correlate with their central metabolic strategy. This is likely to be true, since enzymes
involved in central metabolism require metal cofactors, but it has never been demonstrated for individual cells.
To approach this question, we will develop a secondary-ion mass spectrometry (SIMS) imaging method
capable of simultaneously tracking metabolism and metal content in hundreds of individual bacterial cells. This
is possible due to recent developments in SIMS that have improved sensitivity and throughput to levels
capable of investigating bacterial populations. This technique is capable of measuring single-cell bacterial
metallomes, while simultaneously measuring abundances of isotope labels that were experimentally provided
to trace central metabolism (stable isotope probing). The second aim of this project is to test the hypothesis
that the phenotypic traits examined in Aim 1 are correlated with patterns of gene expression. Currently
available methods are capable of revealing patterns of gene expression in single bacterial cells using amplified
hybridization techniques coupled to fluorescent reporters. We will modify this technique to use a halogen
reporter that is capable of being visualized by SIMS. The abundance of the halogen tag in single cells can be
measured, correlating targeted patterns of gene expression with single-cell bacterial metallomes and bacterial
metabolism. This is significant because it will help us understand fundamental relationships between resource
abundance and central metabolism, and population strategies for allocating resources and metabolism among
individual bacterial cells.

Public health relevance
PROJECT NARRATIVE The proposed research will develop a single cell mass spectrometry method that simultaneously measures three characteristics of bacterial cells: (i) their concentrations of metals (ii) how fast they grew and on what carbon source, and (iii) how abundantly the cells expressed certain genes related to their metabolism. This is relevant for understanding growth of bacterial pathogens in circumstances where hosts try to stop their growth by denying them resources – a strategy called nutritional immunity.